Core-003

The Translational Endeavor core provides for developing a translational workforce and for providing an awards program to enhance research development within OCTRI. The OCTRI Translational Workforce program includes the highly successful research education and career development programs developed over the past 15 years. Research training programs have been implemented specific to the career development phase: undergraduate students; graduate PhD, MD, DMD, and PharmD students; postdoctoral and clinical fellows; and early faculty. The Human Investigations Program provides training in the competencies of clinical and translational research and underlies all programs. Specific training for students includes the physician-scientist track, a clerkship in clinical and translational research, and the FOLIO program for graduate students. The OCTRI Scholar program provides enhanced mentorship and support to mentored career development awardees to increase the odds of achieving research independence. During the next grant period, we will disseminate these successful training modules to the CTSA consortium, particularly biostatistics and bioinformatics. We will enhance our training for early faculty by creating a research development team that pairs an inexperienced clinician or scientist with an experienced research mentor to design, submit for funding, and implement a research proposal with the assistance of the team; this same team will work to problem solve implementation barriers for early researchers. Finally, we will increase the proportion of clinical research professionals who achieve specific research competencies by strengthening and focusing research staff training through an integrated series of training sessions. The OCTRI Pilots and Clinical Studies program provides investigators with funding and resources to advance their research to the next stage. The Pilot Awards Program also serves as a “living lab” for the design and dissemination of research, process, and evaluation methods that impact the efficiency and efficacy of clinical and translational research. The program comprises four key funding mechanisms: OCTRI Catalyst Awards, OCTRI Community Research Coalition Awards, Strategic Investments, and the Biomedical Innovation Program. Over the next grant period we will expand competitive access to our OCTRI partners. We will add an additional mechanism, the Pathways to Independence Award, for early career researchers. This award will fund research likely to impact their career trajectories. We will test this model experimentally, randomly assigning grantees to receive or not receive a package of intensive workforce development and team science interventions. In addition, we will centralize our already rigorous and transparent review process, forming a single standing review committee for all pilot awards that will incorporate external and cross-CTSA reviewers. The OCTRI Awards Program will continue to refine its successful evaluation approach, disseminating findings widely across the CTSA network and the evaluation community.